Pathways regulating fear in the nucleus accumbens

PROJECT SUMMARY/ABSTRACT Excessive associative fear is a hallmark symptom of many anxiety disorders and phobias. These disorders frequently co-occur with substance abuse or mood dysregulation, severely complicating treatment and the recovery process. The nucleus accumbens (NAc), critically involved in reward and substance abuse, is also implicated in aversive processing (ie., fear). Yet how the NAc is regulated by the amygdala and the infralimbic cortex (IL), two critical regions implicated in controlling fear responses, is not clear. Robust glutamatergic axons from the basolateral amygdala (BLA) and the IL innervate both shell and core NAc subregions. To evaluate how fear responses are modulated by these glutamatergic inputs into the NAc, we use an associative fear conditioning paradigm in mice. This involves having mice associate a previously neutral conditioned stimulus (CS; auditory tone) with an unconditioned stimulus (US; mild foot shock) that produces a threat response, quantified by measuring the natural freezing of mice (higher freezing indicates more fear). This associative fear response is reduced by repeated CS-alone presentations, a process called extinction that has major implications for exposure therapy in humans. We have previously shown that optogenetic activation of specific glutamatergic BLA neurons promoted the consolidation of extinction without affecting fear expression. Our pilot data here demonstrate that optogenetic stimulation of BLA terminals in the NAc enhances the consolidation of fear extinction. In addition, we show that inhibiting group I metabotropic glutamate receptors (mGluRs) significantly impairs the consolidation of extinction but has no effect on fear expression. Blocking AMPA receptors, however, reduces fear expression without altering extinction learning. The BLA and IL are critical nodes involved in fear acquisition, expression, and extinction. The NAc is a target of BLA and IL axon terminals and both circuits are important for modulating aversive behaviors. To evaluate if BLA-NAc and IL-NAc glutamatergic projections modulate fear expression and extinction learning, we propose to optogenetically activate or inhibit BLA or IL neurons that project specifically to the NAc during fear testing or extinction (Aim 1). In Aim 2 we will pharmacologically evaluate the roles that AMPA receptors and mGluR1 in the NAc play in fear expression and extinction learning. Next, we will extend characterization of this circuit by further determining which glutamate receptors are responsible for BLA or IL driven fear responses. These novel experiments will improve understanding of the circuitry involved in associative fear processing within the NAc. Because this brain region is also implicated in mood and substance abuse disorders, these experiments will contribute a critical framework for investigations into the mechanisms of co-morbidity.

Public health relevance
PROJECT NARRATIVE/RELEVANCE These investigations will provide a critically important characterization of how amygdala and infralimbic derived glutamatergic release in the NAc modulates associative fear conditioning and extinction. Because the NAc is such a critical node for reward as well as emotion processing, understanding its fundamental functioning in integrating fear responses will significantly enhance our ability to identify pathology. Such information will set a foundation for exploring the repercussions that disruption in one functioning capacity (e.g., fear) of the NAc may have on its other regulatory responsibilities (e.g., reward).